The Epidemiology of Cognitive Decline in African Americans: Identifying Risk and Protective Factors

PROJECT SUMMARY/ABSTRACT
By 2060, 44% of older U.S. adults will be non-Hispanic White compared with 60% in 2020. Cognitive decline in
this growing racially and ethnically diverse older population is a major public health concern. Blacks are
disproportionately affected by Alzheimer’s disease and related dementias (ADRD), and potentially experience
a faster rate of cognitive decline than other groups. Yet, little is known is about the mechanisms underlying this
increased prevalence. Genetic mechanisms do not account entirely for the higher risk of decline and ADRD in
older Black adults, suggesting that other factors may explain this variation. However, the majority of cognitive
aging research derives from studies that have compared Blacks to Whites versus exploring within-group
variability in health conditions, biological, and psychosocial risk and protective factors that may account for
these differences. This study's overall goal is to clarify risk and protective factors underlying cognitive decline
in Blacks by: (1) Examining the relation between high blood pressure (HBP) and domain-specific cognitive
decline and exploring how serious life events and social support modify the HBP-cognition association; (2)
Exploring the relation between inflammation and cognitive decline and how HBP mediates the relation between
serious life events and cognition; and (3) Identifying the consequence of perceived stress on changes in
cognition and evaluating whether HBP and social support moderates the stress-cognition relationship. The
research plan will leverage valuable secondary data from two nationally recognized studies of older adults.
This K01 Award application will facilitate the training and professional development of Dr. Byrd to launch her
career as an independent investigator in the field of aging, cognition, and ADRD. The five-year training plan will
fill gaps in (1) cognitive decline and aging research and (2) stress and coping theories, while building on her
methodological strengths to include (3) advanced longitudinal methods. Dr. Byrd will complete the proposed
research in the rich training environment of Arizona State University (ASU), with co-primary mentorship from
David Coon, PhD, Professor and geropsychologist (ASU) and Roland J. Thorpe, PhD, Professor of Health,
Behavior and Society and minority aging expert (John Hopkin’s University) and nationally and internationally
recognized secondary mentors Peter Lichtenberg, PhD (geriatric neuropsychologist), Keith Whitfield, PhD
(expert on cognition among Blacks) ,Toni Antonucci, PhD (social relations across the lifespan) and renowned
biostatistician Wassim Tarraf, PhD. The proposal addresses Goals B and F of the NIA Strategic Directions for
Research on Aging, which calls for research that seeks to understand 1) the effects of personal, interpersonal,
and societal factors on aging and 2) health disparities among older adults. Our research has the potential to
influence individual outcomes as well as affect policies and programs aimed at improving cognitive health for
the aging population, particularly for Black Americans who are at greatest risk for cognitive decline and ADRD.

Public health relevance
PROJECT NARRATIVE Cognitive decline in Blacks is prevalent, consequential, and understudied. The older U.S. population is expected to increase dramatically by 2030, growing from 35 to 72 million, and becoming significantly more racially and ethnically diverse. The goal of this project is to explore innovative approaches to address variation in risk and protective factors contributing to cognitive decline in Blacks, which may ultimately reduce the risk of subsequent dementia and Alzheimer’s disease development in minority populations.